SCALE-LHS: Synthesize, Coordinate, Amplify, Learn, and Evaluate the AHRQ/PCOR LHS network

PROJECT SUMMARY
The University of Pennsylvania (Penn) proposes to establish the Synthesize, Coordinate, Amplify, Learn, and
Evaluate the AHRQ/PCORI LHS network (SCALE-LHS) coordinating center (“Hub”) for the AHRQ/PCORI LHS
E-StaR Centers. The SCALE-LHS Hub will serve four key functions. First, the Hub will provide timely and
effective coordination of network activities. Second, the Hub will support LHS activities focused on equity – the
newest LHS competency domain – through the creation of an LHS Equity Enhancement Collaborative and
through monthly LHS equity seminars. Third, the Hub will conduct annual formative and summative evaluations
of the 16 LHS E-StaR Centers and the overall network using a robust mixed methods approach. Fourth, the
Hub shall synthesize learnings across the network and disseminate these learnings using a multimodal
approach. SCALE-LHS will leverage the expertise of three complementary centers at Penn: the
implementation science expertise of the Penn Implementation Science Center (PISCE, led by MPI Lane-Fall),
the health equity expertise of the Penn Center for Health Equity Advancement (CHEA, led by MPI Aysola), and
the quality and safety capacity building expertise of the Penn Center for Healthcare Improvement and Patient
Safety (CHIPS, led by MPI Myers). Key activities of the SCALE-LHS Hub will be conducted in partnership with
AHRQ and PCORI staff and will include: planning and facilitating monthly program director (PD) meetings;
planning and executing an annual meeting of PDs and LHS scientist trainees; distributing a monthly newsletter
with network events, relevant readings, and other information of interest to the LHS E-StaR network; training
and supporting LHS scientists in integrating equity considerations and meaningfully engaging with community
members and other stakeholders; gathering program information from PDs and scientists; evaluating programs
and delivering evaluation results to the LHS E-StaR sites; sharing learnings from the network through reports,
white papers and policy briefs, blogs, peer-reviewed publications, and social media; and meeting with AHRQ
and PCORI staff as needed to support the E-StaR centers. Deliverables include annual network reports of
activities and learnings, annual equity reports, publications, and a Hub website with a YouTube channel for
equity seminar recordings. The SCALE-LHS Hub will meet the needs of the LHS E-StaR network by supporting
both operational needs (coordination, evaluation) and aspirational goals (fostering equity and stakeholder
engagement, promoting learning across the network). In so doing, the SCALE-LHS Hub will catalyze the
impact of embedded learning health system scientists in reaching the nation's goals for high-value, high-quality
health care and outcomes.

Public health relevance
PROJECT NARRATIVE The University of Pennsylvania Synthesize, Coordinate, Amplify, Learn, and Evaluate the AHRQ/PCORI LHS network (SCALE-LHS) coordinating center (“hub”) project for the AHRQ/PCORI LHS E-STaR centers will provide comprehensive support for the P30 E-STaR centers. SCALE-LHS will coordinate activities of the centers, identify and amplify the best practices for promoting care equity and meaningful community and stakeholder engagement, evaluate effectiveness of the centers and the overall network, and synthesize learnings and disseminate findings in multiple venues.